APOL1 studies in kidney transplantation consortium clinical centers (ASK-CCC)

ABSTRACT
The ever-widening gap between the need and availability of kidneys for transplantation remains a major
challenge to the goal of transplanting all whom may benefit from it. The kidney transplant waiting list is further
burdened by patients seeking a repeat transplant due to premature transplant loss. Given this mounting
challenge, it is imperative that we use the limited available kidneys more efficiently by matching recipient and
transplant organ longevity and by minimizing discard of marginal kidneys that could be used in better suited
patients. The Kidney Donor Profile Index provides an estimate of kidney quality and African American (AA) donor
race is a variable associated with poorer outcomes. In the general population, AAs are more likely to develop
chronic kidney disease (CKD) than individuals of other races. Recent observational studies suggest that high-
risk APOL1 genotype variants (HR-APOL1), found exclusively in AA, accounts for 70% of this increased risk.
Only a subset of AAs carrying HR-APOL1 develop CKD. In transplantation, recent studies and our preliminary
data suggest that kidneys from AA donors with HR-APOL1 are at a greater risk for graft loss compared to donors
with low risk APOL1 variants (LR-APOL1). Similar to APOL1-asscoiated CKD, only 20-30% of HR-APOL1
kidneys fail within 2 to 3 years of transplant. It appears that HR-APOL1 genotype alone does not predispose to
graft loss but in the presence of a “second hit” they fail prematurely. At the same time, recent data suggests that
AA live kidney donors are more likely to develop CKD than non-AA donors. It is possible that AA living kidney
donors carrying HR-APOL1 are at increased risk for post-donation CKD. To further elucidate the role of donor
APOL1 on recipient graft and living donor outcomes we propose to assemble a cohort of kidney transplant
recipients, from living or deceased donors with African ancestry and address the following specific aims: 1) We
will determine if either HR-APOL1 genotype in the donor kidney or the recipient associates with greater kidney
transplant function decline and graft loss when compared to recipients of LR-APOL1 kidneys; 2) To collect
longitudinal clinical data and biological samples from AA donor kidney transplant recipients to evaluate transplant
related immune- and non-immune “second hit(s)” candidates that trigger early graft dysfunction and failure in
recipients of kidneys from HR-APOL1 donors; and 3) To prospectively collect pre- and post-donation clinical and
laboratory data from AA living kidney donors to determine if HR-APOL1 genotype associates with lower pre-
donation kidney function and greater post-donation kidney function decline, and albuminuria compared to LR-
APOL1 donors. Our consortium is ideally positioned to undertake this study as it brings together a large cohort
of study participants, including Caribbean-Latinos, a group of investigators with complementary expertise, and
state-of-art research facilities. Determining the impact of donor APOL1 gene variants on recipient and donor
outcomes will improve our ability to care for this population.

Public health relevance
PROJECT NARRATIVE Chronic kidney diseases (CKD) affect over 20 million Americans, with a disproportionate higher risk clearly observed in subjects of African descent, especially but not exclusively African Americans. APOL1 genotype high risk variants have been associated with increased risk for CKD in African Americans. This observation has been extended to kidney transplant recipients of African American donors but more research in this area is needed. The APOL1 Long-term Kidney Transplantation Outcome (APOLLO) Research Network will address this important question. The APOL1 Studies in Kidney Transplant Consortium Clinical Center (ASK-CCC) will recruit all transplant recipients of African American deceased donors from transplant centers in Ohio, Michigan, Kentucky, West Virginia, New Jersey and Southern Florida and collect their kidney tissue, blood and urine samples, as well as de-identified health information for at least three years post-transplant. Likewise, similar samples and data will be collected from all living kidney donors of African descent (including African Americans and Caribbean Latinos). Working with other Clinical Centers and the Scientific Data Coordinating Center, together will improve diagnosis, prognosis and treatment of early kidney transplant loss and minimize disparities in outcomes among transplant recipients and donors of African descent.